Targeting MeCP2-Associated Disorders with miRNA Site-Blocking Oligonucleotides

PROJECT SUMMARY / ABSTRACT
Rett syndrome (RTT) is a neurodevelopmental disorder that results from loss-of-function mutations in a methyl-
reader protein known as methyl CpG binding protein 2 (MeCP2); however, despite nearly 20 years of research,
only minimal gains have been made in therapeutic development. While no “curative” intervention strategies exist,
seminal studies show that RTT can be reversed if MeCP2 levels are restored in mouse models. On the surface,
RTT appears to be an ideal candidate for gene therapy; however, MeCP2 is a dose-sensitive gene where even
a 1-fold increase in dosage over baseline could result in a related neurodevelopmental disorder known as MeCP2
duplication syndrome (MDS). The practical challenge created by these narrow dosage requirements is that not
only does MeCP2 delivery need to be efficient across the entire human brain, but each cell must receive the
same, relatively small amount.
The 3’untranslated region (UTR) is an essential site for post-transcriptional mRNA regulation where dozens of
microRNAs (miRNA) and RNA binding proteins additively contribute to fine-tuning gene expression. The impact
of each miRNA on protein levels is generally modest, making strategies that disrupt miRNA regulation of the
3’UTR potentially valuable tools for disorders where the therapeutic window of the target gene is narrow. The
repressive role of miRNAs on MeCP2 expression has been reproducibly shown at multiple sites and when
overexpressed and this strategy can reverse MDS symptoms in mice; however, the therapeutic potential in RTT
remains understudied.
Here we developed a novel strategy that uses a series of locked nucleic acid (LNA) site-blocking antisense
oligonucleotides (sbASOs) designed to “out-compete” endogenous miRNAs for 3’UTR binding and increase /
de-repress MeCP2 expression in a manner that is capped at sub-toxic levels. We anticipate that this strategy
could be a viable intervention strategy for patients with missense and late-truncating MeCP2 mutations, where
the partial loss of function can be offset by increased abundance. In Aim 1, we will conduct dose-response
studies using patient fibroblasts and iPSC-derived neurons with common MeCP2 mutations to determine which
subpopulations are responsive. In Aim 2, we will optimize sbASO delivery in vivo to female Mecp2T158M/+ mice to
establish their capacity to 1) reverse RTT-like symptoms and 2) avoid MDS-like adverse effects. These
experiments will establish proof of concept for the use of site-blocking ASOs in RTT and thereby provide a
foundation to support formal development campaigns. This proposal will provide training in RNA therapeutics,
iPSC modeling of disease, and mouse genetics, which represent three research focus areas that I have identified
as critical for my career development. My mentors and I have developed a training plan composed of didactic
and technical training to prepare me for an independent career in academic research.

Public health relevance
PROJECT NARRATIVE Decreased MeCP2 signaling has been proposed as pathogenic across a broad range of neurological diseases and cancers; however, pharmaceutical and genetic targeting of MeCP2 is challenging because even a modest increase in expression over normal levels results in toxicity. Here we describe a strategy to prevent the binding of negative regulators of MeCP2 expression as a means to fine-tune MeCP2 dosage in increments that plateau at sub-toxic levels. Using the neurodevelopmental disease Rett syndrome as an example, we will demonstrate how this novel approach is a potentially safe and effective mechanism to treat MeCP2-associated disorders.